STEREOSPECIFIC SULFATION OF CHIRAL DRUGS IN HUMANS

The purpose of this study is to elucidate the metabolic fate of the B2- agonist drugs albuterol and terbutaline. Both drugs are administered as racemates (50:50 mixtures of active and inactive stereoisomers). Whereas the main metabolic pathway is sulfate conjugation, the stereochemistry is unknown. The goal is to determine the stereochemical composition of the parent drugs and sulfates in urine, blood and platelets.